Child maltreatment and cardiovascular disease risk: examining psychosocial and immunological pathways in a prospective, longitudinal cohort

PROJECT SUMMARY / ABSTRACT
Over one third of U.S. youth are investigated for child maltreatment (CM) before the age of 18. CM represents an especially potent early life stressor with a profound impact on youth’s psychological and physical well-being. Among other things, CM increases the risk for cardiovascular disease (CVD), which is responsible for 32% of all deaths in the U.S. and the roots of which can already be found during childhood. Thus, a better understanding of the physiological mechanisms through which CM is associated with increased CVD risk is needed to improve the lifelong health trajectories of youth with a CM history, a high-risk yet understudied group, as well as to better understand biological mechanisms connecting early life adversity to later life health more generally. The proposed project will build on the currently ongoing Child Health Study (CHS; HD089922, PI: Noll, Co-I: Schreier), as part of which 675 youth aged 8-13 years who were recently investigated for CM as well as 225 comparison youth without a history of CM are being recruited and followed prospectively. Taking advantage of this unique and exceptionally well-characterized cohort, we will augment the biopsychosocial data already being collected to examine in-depth immune function outcomes. To this end, this project will assess stimulated pro- and anti-inflammatory cytokine production following in vitro microbial challenge, sensitivity to glucocorticoid signaling among white blood cells, and, finally, latent virus regulation, all across multiple timepoints. This will allow us to investigate prospectively and in detail the associations between exposure to CM and immune function outcomes and will be the first study to do so in a sample of recently maltreated youth. Additionally, we will be able to link the resulting immune function outcomes to early indicators of CVD risk among these youth, both by linking to existing measures of cardiometabolic risk in the cohort and further by linking to youth’s administrative records, specifically Medicaid claims data. This will be the first study to examine connections between immune function outcomes and CVD-relevant health care use among youth. Finally, we will be investigating the extent to which malleable protective factors, including youth lifestyle, family and peer environments, may protect youth from the adverse effects of CM on altered immune function outcomes and the extent to which key demographic moderators (age, pubertal stage, sex, race/ethnicity, CM severity) play a role. The interdisciplinary research team includes expertise in the assessment of immune function outcomes and CVD risk among vulnerable youth; the recruitment and retention of prospective cohorts of CM survivors; and the use of administrative records to answer questions pertaining to the well-being of youth with a history of CM. Resulting data will make important contributions to the CM and early life adversity literatures. It will also inform future prevention and intervention efforts with the ultimate goal of reducing the risk of adverse long-term health consequences among some of the most vulnerable individuals in the population as well as reducing the healthcare costs resulting from CM.

Public health relevance
N/A Modified Research Strategy Section RESEARCH STRATEGY SIGNIFICANCE A1. Prevalence and early origins of cardiovascular disease. Cardiovascular disease (CVD) is the most common cause of death in the United States and the prevalence of CVD risk factors (e.g., high cholesterol, hypertension, and diabetes) remains high (1). Several inflammatory and metabolic markers, which themselves are interdependent (2,3), have been identified as important risk factors for CVD. These include adiposity (4–8), elevated cholesterol and blood glucose levels (9–12), and low-grade, systemic inflammation (13–17), although the influence of immune function has been the subject of much less research. The above indicators have been shown to predict CVD risk over years. Further, as listed below, these CVD risk markers are strongly influenced by psychosocial factors, e.g., adversity and chronic psychological stress (18–20). A growing literature shows that the roots of CVD can be found early in life, with implications for CVD risk decades later (21–25). For example, the beginnings of atherosclerosis can already be seen in autopsy studies of young children (26–30) and some inflammatory markers, such as C-reactive protein (CRP), are increasingly being linked to the development of preclinical atherosclerosis among children (31,32). Childhood CVD risk factors in turn predict CVD in adulthood (33). Future CVD risk is further compounded by childhood obesity and diabetes (34–38) and heightened pro-inflammatory profiles during childhood and thereafter (38–40). This is particularly important as many individual CVD risk factors, and their clustering, are not only impacted by the psychosocial environment but also track into adolescence and beyond into adulthood (20,41–45). Given that the presence of these CVD risk factors in young and middle adulthood has also been linked to later life CVD risk more proximally (46,47), it is important to identify contributors to CVD risk among young individuals. A2. Prevalence of child maltreatment and relevance to CVD. Large studies have shown convincingly that over 90% of the risk for common types of CVD (e.g., myocardial infarction) is attributable to modifiable risk factors − including psychosocial stress (19). Several physiological CVD risk factors (e.g., inflammatory and metabolic profiles), can be influenced by psychosocial stressors across all stages of the lifespan (48,49). Child maltreatment (CM) not only represents an extremely pernicious form of early adversity but is also remarkably common. An estimated 37% of U.S. youth are investigated for CM before the age of 18 and ~12% become victims of substantiated CM before reaching adulthood (50). Actual rates are likely higher. Not only do the sensitive nature of CM and the large number of unreported and undetected cases make it difficult to estimate rates of CM, they also make it difficult to establish clear paths from early CM exposure to CVD risk markers and, ultimately, manifest CVD. Recent years have seen an increase in reports focused on links between CM and adult physical health. For example, exposure to CM has been linked to a greater likelihood of engaging in adverse health behaviors – e.g., smoking, drinking, sedentary lifestyles, all themselves risk factors for CVD – and increased risk of obesity, hypertension, CVD and cardio-pulmonary health broadly, autoimmune diseases, type 2 diabetes, and more frequent hospitalizations for the above (51–65). Only very recently has a history of abuse been linked to all-cause mortality in adulthood, including due to CVD (but only emotional and physical abuse were considered, sexual abuse data were not available)(66). This effect was only apparent among women, even though men reported greater frequencies of physical abuse. Although these studies may give the impression of well-characterized associations between exposure to CM and adult CVD, their conclusions are severely limited by their retrospective, cross-sectional nature. In addition to relying on retrospective self-reports of CM history and, at times, physical health, they also frequently use limited samples, e.g., female-only, or abuse but not neglect victims, that preclude generalization to CM survivors more generally. Research on the physical health consequences of CM among exposed youth is sparse but suggests much higher rates of chronic illnesses and hospitalizations for cardio-respiratory disease (excluding asthma) among youth investigated by child welfare services compared to the general population of 0-18-year olds (67–69). Nonetheless, prospective research following individuals from childhood onwards to examine the underlying physiological mechanisms through which CM may influence long-term health is needed to better explain associations between CM and CVD risk and to allow for the earlier identification of high-risk individuals. A3. Physiological pathways connecting child maltreatment to physical health. Existing research on the social determinants of health suggests that experiences of early life adversity, such as CM, program cells of the innate immune system, specifically of the monocyte/macrophage lineage, to respond to challenge in a more pro-inflammatory fashion. Although likely adaptive in the short-term, the resulting more aggressive immune system response may result in a pro-inflammatory immune profile that confers a long-term increase in disease risk, e.g., for CVD, especially when paired with adverse health behaviors, unsupportive social environments, and hormonal dysregulation over the course of the lifespan. Long-term health can further be compromised because the innate immune response is also involved in coordinating the activation of the acquired immune response. Moreover, a concurrent blunted neuroendocrine response may further support this shift towards a more pro- inflammatory immune profile (71). This is thought to be a consequence of compensatory down-regulation of glucocorticoid production following ongoing activation of the neuroendocrine system post-stressors (72). Importantly, and of relevance for CVD risk, glucocorticoids, in addition to their anti-inflammatory functions, also have metabolic effects, including hypertension, dyslipidemia, and insulin resistance (73). Finally, chronic and severe stressors, such as CM, may be particularly detrimental for the developing HPA axis, highlighting the need for research to prospectively follow youth exposed to CM through puberty and beyond (74). Research supporting these associations is, again, largely based on cross-sectional studies of adults retrospectively self-reporting their CM history. A recent meta-analysis has shown poor agreement between retrospective and prospective assessments of CM (172), however, and retrospective CM reports have been shown to be poorer predictors of adult health (173). Nonetheless, these studies suggest that a history of CM and childhood trauma more generally are associated with heightened basal inflammation in adulthood (75–77) as well as lower basal levels of anti-inflammatory substances such as adiponectin and resistin (78) and a dampened cortisol response following the dexamethasone/CRH test (79). Research on physiological risk markers among youth recently exposed to adversity is rare. In one study, children with a history of CM had greater basal levels of TNFα, though not other cytokines, than their counterparts without a CM history (80). Two recent reviews of associations between childhood adversity (broadly) and inflammation among youth found tentative evidence of connections between early adversity and inflammation (81,82); only outcomes relating to systemic, low-grade inflammation were considered, however, most studies included in the reviews were retrospective, and definitions and measures of adversity across the included studies were highly variable. A4. Immune function outcomes following child maltreatment – an underappreciated link to CVD? Immune function represents an important link between CM history and CVD risk. For example, pro- inflammatory cytokines alter the vascular environment – by increasing blood vessel permeability, cell adhesion, apoptosis – to increase the number of local monocytes which, once they mature into macrophages, further maintain a pro-inflammatory environment by secreting pro-inflammatory cytokines (most notably, IL-1β, IL-6, IL-8, and TNFα) (83). Over time, this supports the development of fatty streaks and atherosclerotic lesions in addition to increasing thrombosis risk which may bring about strokes and myocardial infarctions. In fact, the role of macrophages, in concert with other cells, most notably t cells, in the development of atherosclerosis and other forms of CVD is well-established both in human and animal models (84–86). In the steady state, many macrophages differentiate from local monocyte progenitors but monocytes are additionally recruited from the blood stream to sites of inflammation and there differentiate into macrophages (87). Macrophage polarization results in different macrophage phenotypes, often broadly, albeit overly simplistically, referred to as M1 and M2 macrophages, with M1 macrophages thought to be more proinflammatory and more likely to destabilize plaque buildup (84). Both types of macrophages, however, have been shown to be involved in the development of atherosclerosis and to secrete the cytokines assessed as part of the proposed project, thereby possibly potentiating an inflammatory environment which increases CVD risk (88). Prior studies have used in vitro stimulation with lipopolysaccharide (LPS), a bacterial stimulus, to model the behavior of M1 macrophages (89). Despite research linking macrophage responses to CVD risk, existing research has focused primarily on basal levels of inflammation and enumerative measures of the immune system (e.g., numbers of leukocytes). This fails to take into account that the responses of immune cells to pathogens vary and cannot be assumed to be stable across individuals or within individuals over time. Studies involving adults with PTSD have previously found evidence of greater inflammatory responses following in vitro stimulation with LPS even in the absence of enumerative changes to monocytes (90,91), thus underscoring the importance of better understanding immune cell function. Additionally, several studies that simultaneously investigated systemic inflammation and immune function outcomes in relation to psychosocial stress found divergent findings across immune function outcomes and indicators of systemic inflammation (e.g., 92,93), underscoring that immune function outcomes add information beyond what is captured by measures of chronic, systemic inflammation. To our knowledge, no one has investigated immune function outcomes (e.g., stimulated cytokine production; glucocorticoid sensitivity) following in vitro stimulation with bacterial or viral stimuli among youth with a history of recent CM. Greater pro-inflammatory responses to microbial challenge and reduced glucocorticoid sensitivity are indicative of poorer regulation of inflammatory processes, and, if maintained, may increase risk for CVD. Taking advantage of in vitro microbial challenge allows for the evaluation of the functional properties of monocytes under controlled conditions that could not ethically be performed in vivo, and provides intriguing insights into key aspects of immune function. A recent review on the association between CM and later inflammation called for more research to examine the role of inhibitory signals, such as glucocorticoid sensitivity and anti- inflammatory cytokines, due to the scarcity of existing data (76). For this reason, we will also measure stimulated production of IL-10, an anti-inflammatory cytokine involved in the regulation of pro-inflammatory immune responses, especially in response to LPS and pro-inflammatory cytokines such as IL-1β and TNFα. Importantly, the acute inflammatory response to stress relies largely on the innate immune system response, i.e. production of pro-inflammatory cytokines and their regulation via the glucocorticoid pathway. To be able to examine immune function more broadly, we propose to additionally include a measure of latent virus regulation, an indicator of cellular immune system control within the adaptive branch of the immune system. Previous research has linked chronic psychosocial stressors, e.g., attachment anxiety, poverty, trauma, and history of institutionalization, to higher antibody levels of common viruses, including cytomegalovirus and herpes simplex virus, indicating poorer cellular immune system control among individuals faced with stressful environments (94–97). These studies further highlight the importance of focusing on immune function outcomes as several reports have shown no difference in the prevalence of, e.g., herpes simplex virus (96), but instead a failure of the immune system to adequately control viral reactivation. A5. The important role of psychosocial environments and youth characteristics in moderating risk and mitigating CM  immune function  CVD risk associations. Not all youth exposed to CM suffer adverse effects to the same extent. Following a developmental stress buffering model (98), certain protective factors, including health-relevant behaviors as well as family and peer influences, may afford resilience (99,100). For example, experiences of adversity have been linked to an increased risk of poorer lifestyle, including poorer sleep, increased substance use and more sedentary lifestyles which in turn are linked to greater inflammation (55,101–105). For those who are able to maintain healthier lifestyles despite having faced adversity, however, the effects of CM on immune function may be less pronounced (106–112). Similarly, experiencing parental stress and conflict, harsh parenting, and living with parents who themselves have more psychiatric symptoms and a history of trauma has been linked to greater pediatric obesity, poorer glycemic control, and greater levels of pro-inflammatory markers and poorer latent virus regulation among youth (113). In our own research, we have shown that family chaos is associated with systemic, low-grade inflammation among healthy adolescents (92), especially those from poorer families. Importantly, exposure to sensitive and protective parenting during childhood is associated with lower pro-inflammatory tendencies and better self-reported health during adolescence (114) and decreased pro-inflammatory signaling in adulthood. Finally, youth’s peer and parent relationships can influence immunological outcomes such as inflammation, raising the possibility that having better peer and family support and fewer adverse social interactions in one’s larger social and school environment, e.g., being bullied, may further protect youth from the adverse effects of CM (115-117). Existing CM research points to the importance of taking into account person-level moderators, e.g., age, pubertal stage, sex and detailed CM history. One rare prospective study of female sexual abuse victims compared to non-abused controls provides evidence of changing basal morning cortisol between ages 6 to 30 years, such that those with a CM history initially showed evidence of cortisol hypersecretion followed, in early adulthood, by hyposecretion (118). Relatedly, studies following adults over several years or assessing CM  physical health associations among adults of different ages, found that associations between CM and weaker cortisol responses and increased inflammation become magnified over people’s lifetime (79,119). However, prospective research beginning in childhood and incorporating a broader range of relevant physiological outcomes is needed. Puberty is correlated with age but an important moderator of CM  immune function and immune function  CVD risk associations to consider in its own right. Responses of the hypothalamic- pituitary-adrenal axis vary by pubertal stage, and adolescents may be particularly vulnerable to the effects of glucocorticoids (120,121). Relatedly, several studies point to sex differences, though findings of individual reports vary substantially. Both greater rates of hospitalization for cardiorespiratory disease (excluding asthma) among boys with a CM history have been reported (68) as well as more blunted diurnal cortisol patterns, poorer adult physical health and greater all-cause mortality among adult women with a CM history (62,66,122). Additionally, women are more likely to be diagnosed with CVD and immune function is known to differ by sex, at least in adults (123,124). Given that many studies focusing on CM survivors have recruited all- female samples, however, sex differences have not yet received adequate attention in the CM literature. The parent study cohort (P50 HD089922; PI: Noll, Co-I: Schreier), which is evenly split across male and female participants, provides a unique opportunity for a careful investigation of these issues. Lastly, more research is needed to better understand the extent to which detailed CM history influences immune function and CVD risk trajectories (125,126). The proposed project will use detailed information regarding youth CM history derived from their state-level case records (see C1a). By virtue of its rigorous design, and by leveraging the larger CHS infrastructure and comprehensive, multilevel assessment strategy, the proposed project will be extremely well positioned to examine the effects of these key strength-based and deleterious moderators in the context of testing associations between the early-life adversity of CM, immune function, and the development of CVD. A6. Strengths and weaknesses of existing research: summary of scientific premise. Although the physical health consequences of early life adversity have drawn increasing attention, several serious methodological shortcomings of existing studies greatly limit the conclusions that can be drawn from these findings. As noted in recent meta-analyses (e.g., 76,77), definitions of early life adversity are highly variable, even within study samples, such that findings are often inconclusive and difficult to generalize from. In CM research specifically, varying definitions and operationalizations of CM across studies are common as well, and the reasons underlying the variable findings across CM types are still poorly understood. Other methodological shortcomings of existing research include the reliance on retrospective self-reports and lack of prospective, longitudinal follow-up which precludes inferences about causality or even directionality and failure to recruit samples that adequately represent CM survivors (i.e., failure to include cases of neglect or to include males). Importantly, key mechanistic links between CM and manifest disease also remain unclear. Existing studies do not include the breadth of physiological biomarker data, including immune function outcomes, needed to fully understand how CM comes to impact long-term health; further, existing physiological data have not been linked to patterns of actual youth health care use. The proposed project is uniquely positioned to move the field forward in a meaningful way, to address all of the weaknesses outlined above, and to integrate immune function mechanisms as well as important psychosocial moderators. Moreover, by including physiological health outcomes and administrative healthcare data, we will greatly enhance the scientific rigor of the true impact of CVD risk and overall, objectively assessed, health disparities. We will be able to speak to future personalized predictive medicine approaches designed to mitigate the long-term health consequences of early adversity. This may include, e.g., secondary prevention strategies involving the use of anti-inflammatory pharmacological interventions among high-risk individuals to avert progression to clinical CVD outcomes. INNOVATION AND IMPACT B1. Adding a comprehensive assessment of immune function. To our knowledge, no methodologically rigorous, prospective research to date has prospectively investigated the role of altered immune function on later life chronic disease among youth with a history of CM, an incredibly high-risk, vulnerable, and understudied population. Assessing immune function outcomes pertaining both to the innate immune system and cell-mediated immunity within the adaptive immune system will provide important information about the mechanistic connections between experiences of CM and future CVD risk. Although acute inflammation following stimulation with LPS can represent an appropriate reaction to threats such as infections or injuries, heightened responses may be indicative of a pro-inflammatory phenotype that can increase the risk of future chronic diseases. The importance of looking beyond measures of chronic, systemic inflammation is highlighted by existing research including both systemic and stimulated levels of inflammation and finding divergent connections between psychosocial stressors and stimulated vs. basal inflammatory markers (e.g.,93). This may suggest that an exaggerated response of immune cells, e.g., macrophages, to pathogens precedes a state of increased chronic, low-grade inflammation. By culturing cells with a fixed dose of a bacterial and a viral stimulus we are able to measure the magnitude of the inflammatory response mounted by youth’s white blood cells. Further, cortisol represents a key mechanism in the regulation of inflammatory responses. By also stimulating cells in the presence of hydrocortisone, we will be able to assess glucocorticoid sensitivity, i.e., the sensitivity of white blood cells to anti-inflammatory messages. Examining these immune function outcomes will provide valuable insight into potential mechanisms connecting experiences of CM to later life CVD risk. Doing so in this sample of high-risk youth is particularly important as inflammation is also associated with a range of other developmental, neurological, and psychiatric outcomes (180,181) and because CM history is associated with comorbidities and complex clinical presentations (182,183), resulting in an undue disease burden. B2. Linking immune function to administrative records. By linking our comprehensive assessment of youth immune function to Medicaid/CHIP records, this project will be the first to speak to the early clinical relevance of such physiological outcomes. Only limited research connects CM to health care use, almost none of it prospective. No research to date has linked such physiological risk markers to actual patterns of prescription rates, health care use, and early diagnoses of manifest disease. Examining these links among youth is particularly important because 1) the immune and neuroendocrine systems of youth may be particularly malleable; 2) connections between youth physiological outcomes and health care use and early manifest disease are completely unexplored; and 3) the resulting data may be helpful for identifying those youth exposed to CM who are at the greatest risk for future chronic disease and requiring large investments from the health care system, thus informing optimal targets for prevention strategies. We will also be able to investigate whether particular aspects of youth’s lives, e.g., improved lifestyle, family environments, and peer relations, mitigate the adverse effects of CM on immune function and thus, indirectly, on health care use and manifest disease. This information will be invaluable for the development of future personalized intervention efforts. By using this well-defined stress-exposed sample, we will prospectively determine important linkages of immune function with health care utilization and manifest disease (i.e., ICD codes) with important implications for the effects of other forms of early adversity and CVD risk in the general population. B3. Ability to examine how multiple aspects of youth’s psychosocial environment may compound risk or promote resilience while considering important moderators such as age, pubertal stage, sex, SES, and maltreatment history. In addition to understanding how exposure to CM results in greater CVD risk among individuals, it is important to gain a better understanding of how different aspects of youth’s current behaviors and environments may be protective influences and confer resilience in the face of adversity. This is particularly relevant because CM survivors are likely to come from families experiencing multiple hardships; thus, this research has the potential to inform broad policies about best practices for supporting youth from such families. By considering data regarding youth’s lifestyles and broader social environments, we will be able to examine the relative impact of risk and resilience factors on youth health outcomes. Most research to date has been ill-equipped to examine even basic demographic moderators and their role in the CM -> health association; e.g., nearly all research examining effects of sexual abuse focused on female-only samples and almost no research has followed CM survivors across puberty and examined key physiological outcomes. B4. Unique opportunity to leverage an effective prospective cohort study. The current project will benefit from and add to the Child Health Study (CHS) in a number of ways. 1) The CHS is a methodologically rigorous study that is on track to become the largest, prospective cohort of maltreated youth assembled to date. It makes important improvements over existing CM research by recruiting a large sample of youth shortly (i.e., within 12 months) after being investigated for CM from the statewide child welfare data system; following them prospectively during a developmentally important period (late childhood to early adolescence), recruiting equal numbers of boys and girls, including abuse and neglect cases, and finally, by including carefully screened control participants matched for key demographics. 2) We will be able to assess the associations between CM and early CVD risk markers in a large community sample drawn from across the state of Pennsylvania; CVD is the most common cause of death in the United States, and prevention and intervention efforts must focus broadly. 3) A wealth of data will be available on both youth and their caregivers regarding various relevant psychosocial and physiological variables (for details, see C2, C5). All data from the parent project will be available to be linked with the additional outcomes proposed here. The current grant presents an efficient and cost-effective way to add important measures to the CHS that are too time-consuming, labor-intensive, and costly to be covered by the main grant. However, these measures, which include a sophisticated assessment of immune function as well as the integration of medical records, represent invaluable additions to the existing measures strategy of the CHS and will greatly enhance the impact of the study as a whole. B5. Impact. This study will advance both the CM and the broader stress and health literature by taking advantage of a large, methodologically rigorous, prospective cohort that is being built on a representative sample that will result in broadly generalizable findings. It will increase our understanding of the effect of a potent early life stressor, CM, on immune function outcomes. It will move prevention research towards better early identification of the highest-risk youth by linking immune function outcomes to administrative health records and exploring the role of youth’s psychosocial environment in conferring resilience, with the goal of ultimately reducing rates of chronic disease and associated health care costs in this segment of the population. By enhancing the rigor of this science - through prospective design, comprehensive assessment of modifiable strength-based and risk pathways, innovative in vitro assessment of microbial challenge, and objectively obtained health records - we can improve on causal inference regarding the impact of early life adversity on CVD risk and associated health consequences. Support for policies aimed at increasing access to preventive medical care for millions of children exposed each year in the US to early and chronic stress will be bolstered. APPROACH We first discuss relevant preliminary research, including details on the parent study (section C1), followed by an outline of the proposed project including study design, measures, and scientific rigor (C2). We then discuss our analytic strategy (C3), alternative strategies to address potential problems (C4), and end with a section on future directions (C5). Throughout, measures added to the parent study as part of the proposed project are color-coded in blue for added clarity. C1. Preliminary Studies C1a. Parent Study – The Child Health Study (CHS) Sample and design. The CHS is currently recruiting a cohort of 900 children aged 8–13 (50% males) from the Statewide Child Welfare Information System (CWIS) for having been investigated for sexual abuse (n=225), physical abuse (n=225), or neglect (n=225) within the past year and a demographically matched group of comparison children (n=225) screened via CWIS to ensure no history of child welfare involvement. Initial enrollment into the parent study began in August 2017 and is ongoing. Wave 2 began in August 2019. As part of the parent study, the research team has access to youth’s full case records, which are being used to create a full classification index of lifetime CM exposure via the Cicchetti- Manly maltreatment coding system (MCS; 118). As part of MCS coding, information about CM type(s), age of onset/offset, perpetrator(s), severity, and frequency/duration, are extracted for a comprehensive CM assessment. The study intentionally includes founded and unfounded cases of CM. Not only has prior research by our team shown that risk for adverse health outcomes for investigated but ultimately unfounded cases of CM is similar to risk among youth exposed to founded cases of CM (69), it also increases the generalizability of the sample and makes it more relevant to the general population. Non-maltreating caregivers accompany children to Penn State’s University Park campus where comprehensive assessments are conducted. Participating youth-caregiver dyads are asked to return two and four years following their first visit for follow-up visits, allowing us to examine links between CM, immune function, and health care use over a 5-year period. Matched comparisons are recruited from the same regions and matched for child age, sex, race, and SES within each CM type using a stratified block design. To keep the comparison sample free of contamination, which significantly reduces effect size estimates (127), children with any prior Child and Youth Services (CYS) involvement are not eligible. Preliminary data. As of 3/3/21, 439 youth (with a non-maltreating caregiver) have been recruited into the cohort; see Table 1 for an overview of basic demographic information on participants recruited into the cohort to date. Importantly, our success at obtaining peripheral blood from our participants has been excellent thus far, with 91% of youth agreeing to and successfully undergoing venipuncture by a trained phlebotomist, which is an outstanding rate for a sample of recently maltreated, high-risk youth. Using internal seed funds (PI: Schreier), whole blood cultures to assess stimulated cytokine production and glucocorticoid sensitivity (detailed below) have been performed since the beginning of the project and resulting supernatants have been stored at -80ºC. In addition, a small number of samples (n=24) have been assayed to show feasibility and the validity of this approach. As can be seen in Figure 2, our in vitro cell culture protocol is successful at stimulating cytokine production using a bacterial stimulus, as well as at inhibiting this response...